Neotropical Primate Reagent Resource

Nonhuman primates (NHPs) have historically served as crucial animal models for diseases, and for testing of
new therapies and vaccines that cannot be evaluated in rodents. Neotropical primates are used in biomedical
research less frequently in the U.S. than Old World primates, but there is growing interest in these animals as
models due to the close recapitulation of certain clinical diseases and simpler husbandry considerations. Studies
involving marmosets, squirrel monkeys, and owl monkeys comprise the bulk of NIH-funded research featuring
neotropical primates in several areas, including neurodegenerative disorders, infectious diseases, and aging.
In this resource application, we propose to develop a number of marmoset, squirrel monkey, and owl monkey
antibodies to address the gap between project goals and available reagents. Species-matched antibodies can
deplete targeted lymphocyte subsets and allow investigators to probe the impact of specific immune populations
on progression, protection, and recovery. Diagnostic antibodies that distinguish antibody classes and
subclasses, cell surface biomarkers, and soluble mediators will reduce limitations imposed by poor reagent
accessibility. To derive these reagents, the squirrel monkey and marmoset immunoglobulin repertoire will be
exhaustively defined and characterized. Furthermore, a novel antibody specificity assay will be developed with
straightforward adaptability to any species of interest. These resource activities will be integrated with antibody
reagent activities supported by other funding sources.
The antibody resources described here can raise the bar on neotropical primate translational research by
providing investigators validated tools to evaluate the immune response in models of infectious or inflammatory
disease.

Public health relevance
Basic and translational research featuring neotropical primates is growing nationally and globally, but the development of immunological reagents specifically tailored for these animals continues to lag. To optimize the utility of the two most commonly used neotropical primates, we propose to deeply characterize the immunoglobulin repertoire of marmosets, squirrel monkeys, and owl monkeys and engineer species-matched antibodies for lymphocyte depletion. Additional cross-reactive diagnostic antibodies will be identified or generated de novo to support investigators conducting studies in established models of neurodegenerative, infectious, and metabolic diseases.